Determination of the mode of action of the antibiotic pyrazinamide

Project summary/Abstract:
Tuberculosis (TB) is caused by Mycobacterium tuberculosis (Mtb) and is the leading cause of death due to a
single bacterium. In 2020, around 10 million people developed TB worldwide and approximately 1.5 million
people died from TB. TB is curable but the treatment is toxic and long (minimum of 6 month). In the case of drug
resistant TB, the treatment lasts even longer (9 to 24 months) and the chances of patient survival are reduced.
Among the 4 first-line anti-TB drugs used to treat TB, pyrazinamide (PZA) is notorious for its poor activity against
Mtb in vitro. PZA was originally identified in a screen performed in Mtb-infected animals which explains why the
poor activity of PZA in vitro did not stop its discovery as a major anti-TB drug. The main consequence of the poor
activity of PZA in vitro is the lack of understanding of PZA mode of action which results in a reduced capacity to
fight against PZA-resistant TB. We recently established an in vitro model in which PZA displays a high
bactericidal activity against Mtb. In this application, we will validate the involvement of the genes/pathways
identified in a genetic screen to alter PZA susceptibility by constructing selected mutants and measuring their
susceptibility to PZA. Moreover, we will also isolate spontaneous PZA-resistant clones in order to identify bona
fide PZA targets and measure the frequency of resistance to PZA in our in vitro model. The PZA susceptibility
profile of the mutants generated will then be validated in a macrophage model of TB infection. In addition to the
identification of genetic determinants for PZA susceptibility, we will characterize how PZA impacts Mtb
metabolism. Using our in vitro model, we will analyze the metabolome of Mtb using metabolomics and we will
measure the impact of PZA on Mtb respiratory chain functions. Mutants with altered susceptibility to PZA will be
used in addition to wild-type Mtb to elucidate the mechanism of action of PZA. We anticipate that this project will
advance our knowledge on the mechanism of action of PZA and will help the fight against PZA-resistant TB. We
believe this study will also pave the way for the use of in vitro conditions more closely related to the infection
settings in order to improve the discovery and the study of drugs to fight against TB and other infectious diseases.

Public health relevance
Project Narrative: Pyrazinamide is an antibiotic used to treat tuberculosis, an infectious disease caused by the bacterium Mycobacterium tuberculosis, that kills more than 1 million persons every year worldwide. The bactericidal activity of pyrazinamide in vitro is poor which prevents the full understanding of its mode of action and diminishes our capacity to fight against pyrazinamide-resistant tuberculosis. Here, we show that pyrazinamide is highly active against M. tuberculosis when grown in a condition that recapitulates the infection settings and we will use this in vitro model to elucidate the mode of action of pyrazinamide to help the fight against pyrazinamide-resistant tuberculosis.